BLDG. 1066 FIRST FLOOR REPOSITORYMOD 002 : FINAL INDIRECT FUNDING

Building 1066 is a two-story 17,217 gross sqft steel structure constructed in 1994. Thisproject will refurbish a portion of the first floor to accommodate a new freezer repository.This repository will service anticipated sample needs for the MPACT and MATCHclinical genomics programs. The proposed refurbishment plan will maintain themaximum flexibility for the facility in future by keeping some laboratory infrastructurethat would support sample prep laboratory activities as needed in conjunction to theproposed repository space. The new work will include demolition, reconfiguration ofpartitions, doors, new finishes, new plumbing/piping /mechanical/HVAC, fire protectionand electrical work.